Long-term Phenotypic Alteration in the Lung Epithelium Following Early-life RSV Infection

Project Summary/Abstract
Severe RSV-bronchiolitis infection has been associated with the development of asthma later in
childhood. RSV is the primary cause of bronchiolitis in children worldwide, and it is considered the most impactful
risk factor for asthma development among causative pathogens. The therapeutic options are limited. The
mechanism by which early-life RSV (EL-RSV) infection predisposes to asthma later in life is unknown. Our
studies will investigate the mechanism behind asthma development after EL-RSV infection by focusing on long-
term lung epithelial cell alterations generated by epigenetic modification.
We will specifically investigate the role of the innate cytokines IL-1β and IL-33 in long-term lung epithelial
alteration since we had observed these cytokines highly upregulated during RSV infection. The present proposal
provides preliminary data demonstrating that EL-RSV infection generates long-term phenotypic changes in the
alveolar epithelial cell type II (AT2) through epigenetic modification in the Il33 gene promoter. These phenotypic
changes in the lung epithelium after EL-RSV infection likely modify airway allergic reactions later in
life. Additionally, we have identified changes in the ratio of AT2:AT1 cells and altered pulmonary function,
suggesting that EL-RSV infection may generate aberrant lung development or repair. Therefore, we will address
our hypothesis that EL-RSV infection generates long-lasting lung epithelium alterations that impact lung
reactivity to allergens. This leads to the upregulation of innate immune mediators, such as IL-33, that
increase the risk of developing respiratory allergies later in life. This hypothesis will be tested by the
following specific aims:
Aim 1- To determine the acute and persistent mediators and activated pathways responsible for inducing
long-term alterations in the lung following EL-RSV infection.
We hypothesize that EL-RSV causes long-lasting changes in the lung epithelium, leading to lung functional and
structural changes and predisposition to lung pathologies later in life.
Aim 2- To investigate the mechanisms underlying long-term changes in the lung epithelium after EL-
RSV infection by focusing on the RSV-related immune mediators IL-1β and IL-33.
We hypothesize that RSV-related immune mediators IL-1β and IL-33 are critical in generating long-term
alteration of the lung epithelial cells.
Aim 3- To determine if RSV infection generates epigenetic modifications in the lung epithelial cells that
define the long-term alterations in the lung epithelium that contribute to the development of asthma. We
hypothesize that EL-RSV infection drives long-term alteration of lung epithelial cells by modifying the chromatin
organization and accessibility across the genome through histone modification.

Public health relevance
Project Narrative Investigating the mechanism (s) that leads to the development of long-term lung epithelium alteration after early-life RSV infection, which is explored in this proposal, will establish new paradigms that will be crucial for understanding how RSV infection predispose to asthma and develop new interventional therapies that attenuate RSV disease severity and the predisposition to childhood asthma. This application proposes highly innovative ideas to advance RSV immunopathology and asthma research.